CSHL 2025 Systems Immunology Conference

Cold Spring Harbor Conference on Systems Immunology
Cold Spring Harbor, NY
April 22 – April 26, 2025
ABSTRACT
Immune responses are prosecuted by diverse cells and molecules operating in different spatial contexts
within tissues and organs, across different scales, and over time. For example, highly diverse repertoires of
lymphocyte receptors can discriminate between self and non-self antigens, triggering dynamic cell-cell
interactions with both immune and non-immune cells, enabling the delivery of tightly targeted effector functions,
including antibody production and killing of virus-infected cells. Over the past century, critical discoveries have
been made by experimental immunologists studying individual molecules, cells, and their interactions,
increasingly enabled by the application of new technologies. These data have revealed a complexity of
interactions among diverse immune components, but many fundamental issues of how such complexity is
orchestrated and regulated at scale, across whole organisms remain unresolved. Further progress requires an
integration of high-dimensional multi-omic approaches, and computational and quantitative modeling to
interrogate cellular behaviors at the various scales of the system. These properties cannot be analyzed or intuited
by conventional experiments. It is clear that effective collaborations between experimental immunologists and
computational and systems biologists are required to advance our systems-level understanding of immune
responses. This meeting is the fourth in a biennial series aimed at catalyzing a cross-disciplinary exchange of
new ideas, technologies, and analysis methodologies in the rapidly evolving and expanding field of systems
immunology. Building on the successes of our previous meetings held at CSHL in 2019, 2021, and 2023, we
have established this recurring meeting as the leading forum that can sustain a highly interactive community of
Systems Immunologists.
The proposed meeting will focus on recent advances at the interface of immunology and systems and
computational biology, including rational design and applications of engineered immune particles and cells.
Sessions will highlight multi-dimensional experimental platforms, the latest approaches to understand the spatial
context of immune responses, and computational methods that are being used to analyze signaling and genomic
cell states that control discrete effector responses in space and time. Integration of immunogenic, tolerogenic or
pathophysiologic responses at different levels of scale – cellular, tissues and organs in mice and humans will be
explored. Shared and unique design principles that underlie the development, functioning and evolution of the
immune system will be discussed from an analytic standpoint. Throughout the sessions, we will showcase
current efforts to apply systems biology methodology to human immunology and tissue immunity, including high-
dimensional analyses of longitudinal samples obtained from experimental medicine studies in autoimmunity and
infection. The meeting will nurture and foster a community of systems immunologists that are coupling high-
dimensional profiling and imaging with computational and quantitative analyses to deepen the understanding of
immune system states and responses.
Oral presentations will be given by a group of distinguished invited speakers as well as speakers selected
from submitted abstracts. Selected speakers will include primarily graduate students, postdoctoral fellows and
junior faculty aiming for maximal inclusion of young investigators. Of special importance are the two poster
sessions, where many participants can present their work in an atmosphere conducive to informal discussion.
We will also host “meet the speaker” lunch sessions, providing a specific opportunity for students to interact with
distinguished immunologists in the field. The meeting will be of moderate size and we expect about 250-300
people to participate in person, the majority of whom will be presenting a poster or talk, with an additional virtual
audience of 150-200 layered over to provide broadened access to those who would otherwise be unable to
participate. Presenters will be expected to attend in-person with exemptions granted on a case-by-case basis.
The hybrid format will allow broadened access to scientists who would otherwise be unable to attend because
of travel/visa restrictions, family obligations or financial burden. The participation of young investigators, minority,
and women scientists will be strongly encouraged. This proposal includes requested funding to support the
participation of early career Investigators.

Public health relevance
Cold Spring Harbor Conference on Systems Immunology Cold Spring Harbor, NY April 22 – April 26, 2025 PROJECT NARRATIVE The immune system comprises diverse cell types that manifest complex dynamic interactions as they sense and respond to microbes, as well as tissue stress and injury. Decades of experimental research have produced a basic understanding of its components and function. However, how different elements of the immune system work together to generate coherent yet distinctive immune responses, tailored to specific perturbations, is not well understood. To address this challenge, an interdisciplinary community of experimental immunologists and computational and systems biologists have nucleated the emerging field of systems immunology. Harnessing new technologies that enable a high-dimensional assessment of immune cells, their spatial and dynamic behavior and effector functions, developing analysis strategies for these complex datasets, and coupling this with computational and mathematical modeling, an understanding of the immune system is now possible at unprecedented scale and resolution. These technological and computational advances are increasingly being applied to study human immunity in both homeostasis and disease, identifying potential therapeutic strategies across a spectrum of conditions, organs and tissues. Systems immunologists recognize that achieving this potential will require methods and conceptual advances from other scientific disciplines, including computer science, systems and synthetic biology. This biennial international conference brings together leading experts in immunology and systems biology and provides a forum for these scientists to share their latest discoveries. The application specifically seeks support for the active participation of early career investigators and trainees at this conference.